Identification of Pro-aging Thrombospondin-1 Producing Cells Within the Bone Marrow Niche

PROJECT SUMMARY
The bone marrow (BM) niche is a highly complex microenvironment that houses hematopoietic stem cells
(HSCs). These niche cells have been shown to provide instructive cues to HSCs and dysregulation of this
signaling due to aging can lead to impaired hematopoietic activity. With our increasingly aging population,
understanding and developing therapeutics to combat malignancies associated with an aged blood system is of
great importance to both better treat these patients as well as reduce the resulting monetary and healthcare
load. This proposal aims to characterize a recent finding in our lab which identifies thrombospondin-1 (Thbs1)
as a pro-gerontic factor of HSCs and the BM niche. Thbs1 is a well-studied extracellular matrix protein with
notable involvement in age-related changes in other systems, such as the cardiovascular and metabolic systems,
but has not been studied within hematopoiesis. Through competitive HSC transplantation assays, we show that
HSCs derived from aged global knockout (gKO) Thbs1 murine models have young-like engraftment and lineage
potential. Reciprocal transplant assays on these mice also show that intrinsic and extrinsic influence of Thbs1
plays a role in the increased functionality we observe within the global KO. We have since developed a Thbs1-
GFP reporter mouse and have identified that endothelial cells (ECs) and megakaryocytes (MKs) produce Thbs1
within the BM niche. My preliminary data suggests that KO of Thbs1 derived from ECs and MKs recapitulates
the increased HSC functionality observed in young global KO mice. I hypothesize that age-related
dysregulation of cell-specific derived Thbs1 plays a critical role in the aging of HSCs, and, through
targeting Thbs1, we can improve HSC functionality. To test this, we will: 1. Identify which cell-specific KOs
of Thbs1 recapitulate the global KO phenotype whilst assessing possible alterations in hallmarks of HSC aging,
including DNA damage, polarity, and changes in cell cycle, to obtain mechanistic insights. 2. Determine if deletion
or inhibition of Thbs1 can enhance the functional capacity of HSCs expanded within a polyvinyl alcohol-based
platform to be used within BM transplants. 3. Assess the possible effects Thbs1 has during myelosuppressive
insult and determine if targeting Thbs1 can lead to better recovery and preservation of the BM microenvironment
and HSC functionality. Results stemming from this proposal will lead to not only a better understanding of the
basic biology of Thbs1 within hematopoiesis, but also identify the therapeutic potential of targeting cell-specific
Thbs1 to alleviate aged HSC phenotypes.

Public health relevance
NARRATIVE As our population continues to increase in age, understanding how the bone marrow microenvironment changes and affects the precursors of our blood system, hematopoietic stem cells (HSCs), is vital. We have identified thrombospondin-1 as both an intrinsic and extrinsic pro-gerontic factor of these stem cells that, when knocked out, preserves the function of aged HSCs. The therapeutic potential of targeting cell-specific thrombospondin-1 can improve the hematopoietic systems of the elderly, especially after myelosuppressive treatments for bone marrow transplantation.